Pathology and Bioinformatics Core

Project Summary
The goals of the Pathology and Bioinformatics Core are to act as the primary resource for
biomaterials, histopathology expertise, tissue biomarker development, and bioinformatics support
for the Program. This will provide Project Investigators with the necessary expertise and
infrastructure to support the proposed individual projects and facilitate inter-project integration.
The work of the Core will ensure quality control, biobanking, statistical analyses, expert opinion
for study design, availability of equipment and resources to execute experimental approaches,
and integration of data across different datasets and species for the individual Projects.
The specific Aims of this Core are: 1) To provide acquisition, biobanking, clinical annotation, and
histopathologic interpretative services for human and animal tissue samples. 2) To deploy existing
and to develop novel tissue-based biomarker assays. 3) To provide bioinformatic support and
interpretation of genomic and transcriptomic data. 4) To develop and provide methods for
quantitative spatial analysis of multiplexed tissue biomarker data.
Rigorous computational tools, analysis, and expertise will provide necessary resources to each
individual Project in the Program, and overall integration of these data will develop a
comprehensive, integrated model of local molecular and cellular tumor-immune signaling
networks governing immune response and escape in melanoma.

Public health relevance
Project Narrative The Pathology and Bioinformatics Core will serve as a crucial resource for the Program to investigate melanoma signaling networks governing immune evasion and response by providing Investigators with expertise and infrastructure to ensure experimental approaches are soundly designed, implemented, and executed. The efforts of the Core will also ensure that findings made in the individual Projects are integrated into broader conclusions on the signaling networks of melanoma, with particular emphasis on the tumor-immune microenvironment.